Understanding Early Drivers and Therapeutic Targets for Severe Forms of Arrhythmogenic Cardiomyopathy

Summary
Arrhythmogenic right ventricular dysplasia/cardiomyopathy (ARVD/C) is an incurable genetic based cardiac
disease that causes sudden death in young people, including pediatric populations. ARVD/C is termed a “disease
of the desmosome” as majority of mutations are found in desmosomal (junctional anchor) genes. Cardiac
inflammation, manifested as myocarditis, is an early component of ARVD/C, especially in pediatric patients and
patients with mutations in the desmosomal gene, desmoplakin (DSP). However, no models and limited
mechanistic insights exist of a direct causal relationship between inflammation and episodic myocardial injuries
that drive DSP cardiomyopathy and what therapeutics would be impactful. We provide evidence for preclinical
mouse models of DSP cardiomyopathy harboring inflammation, one of which is provoked by acute inflammatory
stress to drive chronic myocarditis in DSP cardiomyopathy, providing platforms to dissect immune cell mediators.
We show significant focal cardiac T cell infiltration in mice with DSP cardiomyopathy and that early use of CD4+T
cell neutralizing antibodies can attenuate ensuing cardiac enlargement and pathology in these mice suggestive
of T cells as mediators of DSP cardiomyopathy. We report the presence of human DSP peptides in a human
immunopeptidome database suggesting DSP’s potential direct involvement as an antigens, which may explain
T cell responses. We show T cell infiltration in explanted human heart tissue from a pediatric patient harboring
two pathogenic DSP mutations, suggesting a T cell response that may be driven by DSP antigenic functions in
the human heart. Early T cell involvement and as mediators of ARVD/C helps explain our report of asymptomatic
patients with pathogenic DSP heterozygous mutations presenting early with recurrent myocarditis prior to the
diagnosis of ARVD/C. Thus, understanding the immune response that underlies DSP cardiomyopathy can
identify vulnerabilities in immune cell and antigen recognition that may drive disease and optimize
immunotherapies for this subgroup. Loss of the gap junction protein, connexin43 (a primary target of DSP protein
loss) is a key molecular alteration in DSP cardiomyopathy and we show that connexin43 upregulation via gene
therapy is therapeutic and prevents myocarditis driven DSP cardiomyopathy. We hypothesize that DSP gene
mutations/loss impact connexin43 loss, which disrupts cardiomyocyte junctional integrity and primes pathogenic
T cells (via DSP antigen exposure) to drive chronic inflammation/myocarditis in ARVD/C. Connexin43 targeted
strategies can therapeutically intervene with myocarditis driven DSP cardiomyopathy. We aim to define: (i) the
immune cell mediators, (ii) triggers, and (iii) therapeutics that intervene with myocarditis in DSP cardiomyopathy.

Public health relevance
Project Narrative This grant is focused on exploiting state-of-the art genetic, molecular, cellular and physiological approaches to determine whether there is a causal relationship between inflammation (manifests as myocarditis) and episodic myocardial injuries that drive desmoplakin (DSP) related cardiomyopathy in mice and humans. Targeted gene therapy strategies to therapeutically alter myocarditis driven DSP cardiomyopathy will also be tested.